Electronic photoreceptors for restoration of sight in retinal degeneration

Project Summary/Abstract
Retinal degeneration leads to blindness due to loss of photoreceptors. However, a significant
number of the inner retinal neurons survive to a large extent, providing an opportunity for a
restoration of vision by electrical stimulation of these cells. We developed a photovoltaic
substitute of the photoreceptors, which directly converts light into pulsed electric current in each
pixel, stimulating the nearby second-order neurons. Clinical trial in patients blinded by atrophic
Age-related Macular Degeneration confirmed the safety, stability of such implants and spatial
resolution closely matching the 100µm pixel size. However, the current geometry of the flat
bipolar pixels does not allow significant decrease of the pixel size due to rapid increase of the
stimulation threshold with smaller pixels.
We will develop three complimentary approaches to this challenge, which should
enable decreasing the pixel size down to 20µm and thereby enable highly functional restoration
of sight. Instead of using local return electrodes in each pixel of a bipolar design, we will use
monopolar pixels whose active electrodes can serve as both, anodes and cathodes. In this
design, the return current flows via dark pixels using integrated shunt resistors, which enables
deeper penetration of electric field into the retina. In addition, we will use optically-controlled
current steering for enhanced field confinement. It enables adjustment of the lateral and axial
confinement of electric field in tissue by spatiotemporal optical modulation of the photovoltaic
array. We will also use pillar electrodes: utilizing the migration of the inner retinal neurons into
the voids in the subretinal implant, the stimulating electrode on top of a pillar gets closer to
the target cells. This way, the stimulation threshold is decreased and selectivity of the bipolar
cells stimulation increased. All three approaches can be combined, each already
demonstrated very encouraging preliminary results, and now they will be developed to the full
extent for eventual transition into clinical testing.

Public health relevance
Project Narrative Clinical trial of the photovoltaic substitute for the lost photoreceptors in AMD patients confirmed the safety of such implants (PRIMA) and spatial resolution closely matching the 100µm pixel size. This proposal describes three complimentary approaches to advance this technology towards 20µm pixels in order to enable visual acuity exceeding 20/100, which should allow highly functional restoration of sight. All three approaches, including the pillar electrodes and optical current steering, demonstrated very encouraging preliminary results, and will now be developed to the full extent.